DP24-004, PRC CORE: SDSU Prevention Research Center

PROJECT SUMMARY/ABSTRACT
The overarching goals of the proposed Taking on the Heat: Community Action to Adapt an Extreme Heat
Intervention San Diego State University/ San Diego State University-Imperial Valley Prevention Research
Center (PRC) is to reduce the disparate health impacts of extreme heat in disproportionately impacted
populations. The PRC will be organized into a PRC Center Component (PRC-CC), a PRC Core Research
Project Component (PRC-RP) and a PRC Network Component (PRC-N). The PRC-CC’s primary aim will be to
build, leverage, and support the necessary partnerships and infrastructure to expand and sustain institutional
and community capacity to conduct the PRC-RP and additional applied prevention and dissemination and
implementation research.
The PRC-RP will focus on the chronic disease prevention priority category of reducing UV overexposure and
mitigating the effects of extreme heat. We will address the science gap of how communities interested in
using evidence-based interventions (EBI) for mitigating the health effects of extreme heat can improve uptake
through implementation science methods. Using high-quality public health Community-Based Participatory
Research and implementation science methods, we will adopt and implement the Phoenix Heat Action
Planning Guide Heat Action Planning Guide for Neighborhoods of Greater Phoenix from the U.S.
Environmental Protection Agency Community Actions Database in the historically disinvested agricultural
setting of Imperial Valley, CA. The Exploration, Preparation, Implementation, and Sustainment (EPIS)
framework and community-informed participatory planning process called Implementation Mapping will drive
the adaptation and implementation of the EBI through workshops, focus groups, capacity training, and home
and school visits to communities facing heat inequities.
The PRC-N will participate in the PRC Network to leverage the expertise of the network members to inform
individual core research project and center activities and advance the network’s collective impact in public
health prevention research, policy, and practice.

Public health relevance
PROJECT NARRATIVE The goal of the San Diego State University/ San Diego State University-Imperial Valley Prevention Research Center (PRC) named “Taking on the Heat: Community Action to Adapt an Extreme Heat Intervention” is to reduce the health effects of extreme heat in communities that are most impacted. Our Core Research Project will work to understand how communities can use implementation science methods with evidence-based interventions, to better protect health during extreme heat.